Core B: Animal Core

Project Summary/Abstract - Core B This core unit serves as a central resource for all control (C) and high fat (HF) fed animals used by all investigators in the Program Project. Core personnel are responsible for continuing and up-to-date assessment of animal requirements for all Projects. They ensure timely ordering, delivery, and proper housing of animals. All animal surgery (except some post-mortem tissue removal) is conducted and/or supervised by Core B personnel. This includes production of HF feeding induced hypertension and appropriate control or sham- operated rats, most routine tissue removal for in vitro analysis, and instrumentation of rats for chronic hemodynamic monitoring. All animals used in the Program Project have their blood pressure carefully and reliably quantified by Core B personnel either directly (implanted arterial catheter or radiotelemetry transmitter) or indirectly (systolic pressure by tail-cuff sphygmomanometry) prior to or as part of each experimental protocol. Daily animal husbandry, health surveillance and record keeping also are the responsibility of Core B personnel, in association with the staff of University Laboratory Animals Resources (ULAR) of Michigan State University. Core B personnel also are responsible for developing and implementing new physiological techniques for evaluating cardiovascular function in rats. A major advantage of the Animal Core is that it facilitates the most efficient use of animals by Program Investigators. Our in vivo protocols also are designed to maximize the amount of data collected from a single animal. This is achieved through use of long-term repeated measurements of cardiovascular parameters where possible, rather than studying separate groups of rats at each time point of interest. At the end of chronic in vivo protocols, tissue samples from the rats are distributed to one or more Program investigators for further study.

Public health relevance
Project Narrative - Core B Core B will purchase, house and maintain all animals used in this Program. It also will generate the animal model of obesity-associated hypertension (and appropriate control animals) to be used by all investigators, as well as perform routine phenotyping of all rats, including cardiovascular measures and metabolic variables. Finally, Core B personnel will perform all device implantation surgeries necessary for the in vivo studies planned in Projects 1 and 3, and assist in the conduct of the planned in vivo protocols, allowing uniformity and control over the animal model of obesity and thus enable more accurate and precise comparisons of findings in the model from the three main projects in the Program.